Probing co-transcriptional gene regulatory logics in human transcriptomes

PROJECT SUMMARY
The architecture of mammalian genes enables the production of multiple transcripts by using alternative
promoters, alternative termination sites, and differentially spliced exons, which greatly expand the coding
capacity of our genomes. We recently discovered that exon splicing can activate cryptic promoters located
nearby and that these new promoters often arise near annotated internal exons creating “hybrid” exons that
can be used as both first and internal exons in different transcripts. The regulation of these processes has
profound impacts on gene expression, and yet the specific mechanisms are poorly understood. Indeed, key
gaps in our understanding of co-transcriptional gene regulation include the specific mechanisms and the trans-
factors involved in the splicing-dependent regulation of transcription and the roles of spliceosome components.
Moreover, since exon splicing influences transcription from the most upstream and nearby promoter, it is
unclear how the activation of a new promoter affects the expression of alternative promoters in the same
genes. The goal of my lab is to understand the molecular processes underlying the functional coupling
between transcription and RNA-processing, aiming to uncover novel mechanisms of gene regulation in
important contexts. In this proposal, we will combine genetic, molecular, and genomic techniques with high-
throughput computational analyses to address two key aspects of co-transcriptional gene regulation. First, we
will focus on how splicing activates transcription from hybrid exons and identify key cis- and trans-factors
involved in the splicing-dependent activation of promoters of hybrid exons. Also, we hypothesize that splicing-
dependent promoter activation affects transcription from nearby alternative promoters by modulating their
chromatin environment. We will then work on how promoter activation modulates transcription from alternative
promoters and discern the mechanism behind promoter interference that has profound impacts on gene
regulation. Furthermore, we will explore the effects of promoter activation on other promoters nearby during
stem cell differentiation to define their contribution to gene regulation and cardiac identity. Our research will
result in insights crucial to uncovering the molecular events that cumulatively establish co-transcriptional gene
regulatory networks. Ultimately, our findings will lead to the development of new computational tools to predict
gene regulatory networks and design molecules to control gene expression with therapeutic benefits.

Public health relevance
PROJECT NARRATIVE Proper gene expression is crucial for cellular differentiation, development, and disease. The goal of this proposal is to determine the molecular mechanisms underlying co-transcriptional gene expression regulation in human cells and during stem cell differentiation. Our findings will uncover novel layers of gene regulation that will set the path to develop new strategies to control gene expression with therapeutic benefits.